Chromatin Remodeling Proteins

We have characterized CReMM, a new member of the CHD family of chromatin remodeling proteins. CReMM is rearranged in a large fraction of osteosarcomas, implicating the disruption of this new protein in an important human disease. This protein was isolated by immunocloning from marrow stromal cells, and contains motifs for interaction with steroid receptors. The protein contains two chromodomains, a SNF2/helicase remodeling domain, a SANT domain, and an A/T hook DNA binding domain. Unexpectedly, the protein interacts with both Pol II and Pol I promoters, and is localized either to the nucleoplasm or to the nucleolar fibrillar transcription centers (FTC) in a phosphorylation dependent manner. These findings suggest CReMM is a new chromatin remodeling factor that is involved in both Pol II and Pol I transcription.